New Base-Promoted Oxidative and Reductive Coupling Reactions

Project Summary
There is a critical need to develop synthetic methods that improve access to chemicals required for the
discovery and production of new medicines. The long-term goal of this research program is to invent
generalizable base-promoted reactions that address major limitations in organic synthesis. In contrast to widely
used traditional base-promoted reactions that combine a pronucleophile with an electrophile, this proposal
introduces general strategies for oxidative and reductive coupling reactions that combine two nucleophiles or
two electrophiles, respectively. These protocols unlock a wide array of new base-promoted reactions that employ
common functional groups to provide previously difficult-to-access products. Specifically, haloarenes are used
as a new type of oxidant to transfer halogens to transiently formed carbanion species that enable oxidative
coupling processes of mildly acidic C–H bonds. This process greatly streamlines the synthesis of ether and
amine-containing arenes, alkenes and alkanes. Additionally, base-activation of disilanes generates silyl anions
that transform electrophiles into nucleophilic species for C–C bond-forming reactions. This approach is used for
the monoselective substitution of trifluoromethylaryl C–F bonds to access new difluoroalkyl chemical space and
for the combination of alternative electrophile classes to form complex Csp2-Csp3 and Csp3-Csp3 carbon
backbones. The methods in this proposal rely on base-activation strategies and thus have distinct scope,
selectivity and utility over alternative means of reaction promotion such as the use of transition metals,
electrochemistry or photochemistry. These impacts are demonstrated through single-step access to compounds
that were either previously inaccessible or required tedious multistep syntheses and through shortened and
modular routes to specific drug substructures. The reactions can also be used on complex drug-like structures
to modify and diversify bioactive molecules. Upon completion of this work, chemists will have at their disposal a
set of powerful reactions that increase the efficiency, practicality and range of access to molecules desired in
the pharmaceutical industry.

Public health relevance
Project Narrative The ability to rapidly and selectively prepare targeted chemical structures is vital for the discovery and production of new medicines. This research program will develop synthetic capabilities that improve access to compounds needed in the pharmaceutical industry, such as functionalized arenes, amines and fluorinated motifs. This will be accomplished through the use of inexpensive bases to promote new oxidative and reductive coupling reactions between abundant nucleophiles and electrophiles, respectively.